MOUSE CHROMOSOME ANALYSIS &SORTING

In cooperation with Dr. Sandya Narayanswami at the Jackson Laboratory, we are collaborating on a project to sort mouse chromosomes for the purpose of generating IRS-PCR (inter-spersed repeat ) probes to be used for contig mapping of the mouse chromosome. Interleukin-2 stimulated spleen cells from the strain C57BL/6J are being supplied to the NFCR on a weekly basis (every Wednesday) for sorting different chromosomes. Appropriate Robertsonian strains in a C57BL/6J background are being used to purify chromosomes that are resolvable in bivariate profiles (10+13, 14+15, and 4+5).